Research and Mentoring on Neurocognitive Disparities in Aging

PROJECT SUMMARY
The proposed K24 Midcareer Investigator Award in Patient-Oriented Research aims to best enable the Principal
Investigator, Dr. María Marquine, to advance research on neurocognitive disparities in aging and Alzheimer’s
Disease and Related Dementias (ADRDs) among Hispanics/Latinos/as/x (henceforth Hispanics). Dr. Marquine’s
research program has centered around two major themes: 1) the identification of risk and protective factors for
neurocognitive decline among older Hispanics with and without HIV, and 2) the development of tools for the
accurate identification of neurocognitive impairment among Spanish-speakers in the United States. More
recently, she has extended this latter focus to include the use of ubiquitous mobile technology for the
identification of ADRD risk. Dr. Marquine is passionate about mentoring and supporting the advancement of
early career scientists, particularly those from underrepresented minority (URM) backgrounds. Approximately
80% of her mentees have been from disadvantaged backgrounds, and her mentees have spanned various
career stages, from high-school to early career faculty. She is currently a co-Investigator on two NIA-funded
research education programs, the San Diego Alzheimer’s Disease-Resource Center for Minority Aging Research
(AD-RCMAR) and the University of California San Diego (UCSD) Advancing Diversity through Aging Research
(ADAR) program, and Deputy Director of an R25 Research Education Program on aging and HIV. She is also a
mentor in the UCSD Hispanic Center of Excellence, several NIH-funded T32 training programs housed at UCSD,
and the San Diego State University (SDSU)/UCSD Joint Doctoral Program in Clinical Psychology. Attaining a
Midcareer Investigator Award would allow Dr. Marquine protected time to continue advancing her research
program in neurocognitive disparities and ADRD, deepen her commitment to mentor junior clinical scientists in
the conduct of research in this area, and obtain formal training in mentoring and leadership skills. The award
would also provide support for the development of neuropsychological normative standards to detect
neurocognitive impairment associated with ADRDs among older Spanish-speakers, which is a necessary step
toward the advancement of ADRD research in this understudied group. In her research and mentoring activities,
Dr. Marquine will leverage resources available within three major research centers at UCSD, namely, the Stein
Institute for Research on Aging, the Shiley-Marcos Alzheimer’s Disease Research Center, and the HIV
Neurobehavioral Research Program. Together, these research centers have built and maintain a highly effective
research and training infrastructure that will serve as an important resource for Dr. Marquine’s own research
program and that of her mentees.

Public health relevance
PROJECT NARRATIVE The proposed K24 Midcareer Investigator Award in Patient-Oriented Research aims to best enable the Principal Investigator to: (1) advance her research program in neurocognitive disparities in aging and Alzheimer’s Disease and Related Dementias (ADRDs); (2) deepen her commitment to mentoring junior clinical scientist pursuing research careers in this area, particularly trainees from underrepresented minority backgrounds; and (3) develop tools to most accurately detect neurocognitive impairment associated with ADRDs among older Spanish- speakers in the United States. These activities will advance the field of ADRD disparities research and support the diversification of the aging research workforce.